Mapping Genotype to Developmental Course Across an Autism-Schizophrenia Gradient

Autism spectrum disorders (ASD) and schizophrenia (SCZ) are highly heritable neuropsychiatric disorders
associated with substantial phenotypic heterogeneity in developmental course. Across both disorders, while
some individuals struggle with developmental delays and have co-occurring intellectual disability (ID) from a
young age, others attain milestones without difficulty and show few challenges until later in life. This
heterogeneity in developmental course has challenged efforts to predict clinical prognosis, discover biological
mechanisms, and develop personalized treatments. Both disorders are also associated with genetic risk
factors and gene expression patterns that suggest a possible genetically-associated neurodevelopmental
gradient from ID to ASD to SCZ. To assess how well this gradient maps on to developmental course in ASD
and SCZ, the PI will analyze phenotypic, genetic, and neurobiological data from over 43,000 participants
(including over 35,000 ASD children and 8,000 SCZ adults) and over 1,900 postmortem human brain tissue
donors (including over 290 fetal donors and 1,600 adult donors). Genetic variation associated with ID, ASD,
and/or SCZ will act as a bridge between phenotype and biology in this research. In Aim 1, the PI will distinguish
subgroups of ASD children based on behavioral trajectories and subgroups of SCZ adults based on diagnostic
trajectories, then compare the subgroups by key clinical outcomes. In Aim 2, the PI will characterize trajectory
subgroups by average common and rare genetic burdens associated with ID, ASD, and SCZ, and average
social-environmental exposure to childhood adversity, then test additive and non-additive risk models
predicting subgroup membership. In Aim 3, the PI will evaluate the expression consequences of common
variation associated with ID, ASD, and SCZ in neuropsychiatric risk genes across distinct developmental
timepoints and cortical cell types. Altogether, ID/ASD/SCZ-associated genetic variation may show consistent
associations across phenotype and biology, which can highlight putative biological candidates for further
inquiry. To support her research aims and training goals, the PI has assembled an interdisciplinary committee
of eminent scientists including Jordan Smoller (primary mentor), Elise Robinson (co-mentor), Michael
Talkowski, Caroline Uhler, Aarno Palotie, Michael Gandal, Somer Bishop, and Evan Macosko. Building on her
strong foundation in psychology, genetics, and neuroscience, the PI will deepen her statistical training in large-
scale phenotyping approaches, statistical genetics methods, and functional genomics tools, and broaden her
professional skills to prepare her for a faculty position. Her career development will be further bolstered by the
highly collaborative training environments and extensive research infrastructures at the MGH Center for
Genomic Medicine and the Broad Institute of MIT and Harvard. The PI’s completion of this proposal will inform
biological mechanisms contributing to developmental course, developmental time windows for targeting
therapeutic interventions, and personalized treatments tailored to genetic and environmental risk profiles.

Public health relevance
PROJECT NARRATIVE Across autism and schizophrenia, substantial variation in developmental course has challenged efforts to estimate clinical prognosis, identify biological mechanisms, and develop personalized interventions. This proposal will characterize the relationships among variation in developmental trajectories, genetic and environmental risks, and neurobiological processes in large samples of children with autism, adults with schizophrenia, and postmortem brain tissue donors. The findings from this research will inform our understanding of biological mechanisms and our tailoring of interventions to individual risk profiles in both autism and schizophrenia.